Death receptor signaling as an immune checkpoint in tumor-specific iPSC-T cell function

PROJECT SUMMARY
Realizing the potential of cell therapies for cancer requires advances in manufacturing, cell potency, and in vivo
durability of anti-tumor responses. In vitro generation of T cells from induced pluripotent stem cells (iPSCs) can
advance these goals by enabling complex gene editing in clonal, self-renewing, genomically validated “master”
iPSC lines from which therapeutic T cells can be produced. This promise is tempered by the largely unknown
objective function of these cells, particularly their in vivo persistence. Development of PSC-T cells as viable
alternatives to autologous T cells therefore requires a mechanistic understanding of their responses to tumor
encounter and, from this, clear strategies to achieve functional parity with PB T cells.
In this proposal, we examine the hypothesis that autocrine/paracrine Fas/FasL signaling is a critical checkpoint
limiting the persistence of antigen-specific PSC-T cells during serial antigen encounter. We base this hypothesis
on our observations that: a) PSC-T cells exhibit a de novo effector/memory-like gene expression program,
including expression of Fas and its ligand, FasL, despite expression of naïve surface markers; b) that Fas and
FasL expression increases on PSC-T cells following serial antigen encounter; and c) that, even in the absence
of tumor-expressed FasL, antibody blockade of FasL on PSC-T cells markedly enhanced serial tumor killing.
To test this hypothesis, we will use the artificial thymic organoid (ATO) method, developed by our group, to
generate mature, CD8+ TCR-T and CAR-T cells from human iPSCs. We will leverage the ability to generate
clonal, isogenic iPSC lines with deletion of FAS, FASLG, or both, to interrogate the role each gene plays in PSC-
T cell response to serial antigen exposure in a CD19 CAR-T model. This will include testing the effect of
FAS/FASLG gene deletion on depth and duration of in vivo tumor responses and competitive fitness in a
xenograft mouse model; and testing in vitro efficacy of FAS/FASL-deleted PSC-T cells against patient-derived
B-ALL. As a potential strategy for therapeutic PSC-T cells development, we will use both immunocompetent
syngeneic mouse models and long-term PSC-T cell engraftment in NSG mice to demonstrate the safety of
Fas/FasL disruption with respect to autoimmune disease, uncontrolled proliferation, and transformation.
Our goal in characterizing this regulatory pathway in PSC-T cells is to significantly advance our understanding
of PSC-T cell anti-tumor function to further their potential as a promising T cell source for cancer therapy.
Furthermore, mechanistic understanding of the role of autocrine/paracrine Fas/FasL in the antigen-specific
responses of PSC-T cells may more broadly inform our understanding of this potentially important pathway in T
cells from other sources.

Public health relevance
PROJECT NARRATIVE Engineered T cell therapies for cancer have demonstrated the potential to treat cancers otherwise unresponsive to existing treatments, however, solving barriers to access and expanding the number of cancer types responsive to T cell therapies requires new innovations. This project seeks to develop the potential of pluripotent stem cell- derived T cells (PSC-T) as an effective and readily available source of T cells for future cell therapies through studying a way to enhance their therapeutic efficacy against tumor cells.